Project 1: Sato

PROJECT 1 – PROJECT SUMMARY
Impairment in social behaviors is a core symptom in autism spectrum disorder (ASD), yet the underlying
mechanisms of this dysfunction are not known. The current project aims to provide a mechanistic link between
a highly penetrant, syndromic ASD risk gene, MEF2C, and the development of social deficits. Our preliminary
data show that the reduction of Mef2c in inhibitory interneurons, rather than excitatory neurons, is critical for
establishing social deficits. We will extend these preliminary data to test the hypothesis that a specific subtype
of interneuron (parvalbumin-positive interneurons or PV-INs) is a critical circuit component that links Mef2c to
neurotypical social behavior. In Aim 1, we will employ in vivo calcium imaging to monitor changes in the activity
of PV-INs and other major neuron classes in the prefrontal cortex to better understand altered circuit activity
patterns that link to social deficits in Mef2c mutant mice. In Aim 2, we will determine altered gene expression
patterns in PV-INs and other types of neurons in Mef2c mutant mice, including a novel approach to tag neurons
that were active during social interaction. Together, our study will clarify how excitatory and inhibitory circuits for
social information processing are affected in an ASD mouse model. The project will benefit from the CNDD cores
for behavioral assays, in vivo imaging, bioinformatics approaches, and advanced biostatistical consulting. The
career development and mentorship will help the PI obtain future NIH R01 funding to facilitate the transition to
an established investigator in the field of neurodevelopment and its disorders.